CORE--DEVELOPMENTAL FUNDS

Description: The Developmental Funds budget includes funds for three categories of support: New Investigator, Pilot Projects, and Methods Development Pilot Projects. A total of $40,000 per year is requested in the budget for competitively awarded pilot projects including methods development. The request for support for new investigators is $150,000.